Molecular Basis of Viral Infectivity

DESCRIPTION (provided by applicant): This training program in mechanisms of viral infection will train 6 predoctoral students and 4 postdoctoral fellows per year. The goal of this training grant is to provide students who 1) are well trained in the study of mechanisms of viral replication, 2) can investigate human viruses causing disease, such as the human immunodeficiency virus and herpes viruses, 3) can investigate new antiviral compounds and vaccines to prevent or treat viral diseases, 4) can study viruses that are potential agents of bioterrorism, and 5) can use viruses to probe the cellular and molecular biology of prokaryotic and eukaryotic cells. Nearly all of the predoctoral applicants will have an undergraduate education in biology or chemistry. All of the predoctoral trainees will be graduate students in the Program in Virology, an inter-faculty degree-granting program. The laboratories of the training faculty are located at Harvard Medical School and affiliated hospitals, Harvard School of Public Health, Dana-Farber Cancer Institute, Children's Hospital, and the Harvard University Fairchild Laboratory in Cambridge. The Program in Virology students will pursue a broad biological program of study with courses in virology, molecular biology and genetics, biochemistry, cell biology and immunology. These students will also attend seminars, research meetings, and perform 3 laboratory rotations. Faculty curriculum advisors will provide guidance for the students throughout their training, and they will choose their advisors from the Program in Virology faculty. Students will take their preliminary qualifying examination during their second year, and after their examination, a dissertation advisory committee will be formed to provide advice on the progress of their research. Upon successful completion and defense of the dissertation, the student will be awarded a Ph.D. degree in virology. Postdoctoral training takes place in the laboratories of the training faculty. Consistent with the specialized nature of postdoctoral training, the primary program will be designed by the faculty advisor, but this training program will utilize the retreats, courses, and seminars of the Virology Program to enhance the training and education of the postdoctoral trainees. In addition, Dr. Knipe, Dr. Sean Whelan, and Dr. Priscilla Yang will review annual progress reports from the postdoctoral trainees, and meet with and advise the postdoctoral trainees on their research and career paths throughout their tenure as postdoctoral fellows at Harvard. Predoctoral and postdoctoral trainees will participate in a training program in the ethical conduct of science. An active and previously successful program by the training faculty and Division of Medical Sciences is described for the recruitment of underrepresented minority trainees.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this training grant is to provide students who 1) are well trained in the study of mechanisms of viral replication, 2) can investigate human viruses causing disease, such as the human immunodeficiency virus and herpes viruses, 3) can investigate new antiviral compounds and vaccines to prevent or treat viral diseases, 4) can study viruses that are potential agents of bioterrorism, and 5) can use viruses to probe the cellular and molecular biology of prokaryotic and eukaryotic cells.